Role of Desmoglein 1 in Keratinocyte-Melanocyte Communication and Melanoma

Project Summary/Abstract
Melanoma arises from transformation of melanocytes (MCs) in the basal layer of the epidermis where they are
surrounded by keratinocytes (KCs). While
promote
extrinsic
much effort has been devoted to determining how MC driver mutations
melanoma development, tumorigenesis also depends on non-genetic environmental factors. How
factors cooperate with driver mutations to promote MCs to adopt a particular cell fate is poorly
understood. We identified the keratinocyte (KC)-specific cadherin Desmoglein 1 (Dsg1) as a mediator of KC:MC
communication. Best known as a keratinocyte-specific adhesion molecule of stratified mammalian epithelia, we
demonstrated that its transient downregulation like that occurring in response to ultraviolet radiation (UV) initiates
a protective tanning response in MCs. However, chronic Dsg1 loss stimulates pathogenic pro-inflammatory
cytokine production. Our work supports the hypothesis that melanoma cells hijack UV response pathways to
downregulate Dsg1 in neighboring KCs, creating a pro-inflammatory environment that drives transforming MCs
and melanoma cells to adopt new cell fates and bypass check points to tumor progression. To test this, we will:
1) Determine the stage-wise mechanisms that promote MC transformation and melanoma development
through KC Dsg1 loss. We propose that KC Dsg1 loss alters adjacent MCs through paracrine and contact-
mediated signaling, acting as a non-genetic hit to drive melanomagenesis. Using novel transcriptional reporters,
barcoding with scRNA-Seq to track cell fates, and label free phase imaging to track single cell behaviors, we will
address how KC Dsg1 loss helps a) MCs with driver mutations in BRAF and the tumor suppressor CDKN2A and
b) paired non-invasive and invasive melanoma cells adopt cell fates that promote melanoma progression. Human
3D epidermal co-cultures and a novel Dsg1-deficient cKit-driven oncogene mouse model will be used to
determine how cell fates adopted in response to Dsg1 loss drive oncogenesis in the context of the epidermal
environment. 2) Determine how melanoma cells downregulate KC Dsg1 to promote their own tumorigenic
potential. We hypothesize that mutant MCs or melanoma cells chronically suppress Dsg1 in perilesional KCs to
create a pro-tumorigenic KC:melanoma cell niche. Like UV, paracrine signaling from melanoma cells increases
the activity of the transcriptional repressor SNAI2/Slug, decreasing nuclear Grhl1, a known transcriptional
regulator of Dsg1. We will determine how melanoma cells mediate transcriptional reprogramming of KCs for their
own benefit. The extent to which oxidative stress, present in both UV-exposed and melanoma tissues,
cooperates with melanoma-derived factors to reduce Dsg1 will be determined. Transcriptional and proteomic
analysis will be used to validate the spatiotemporal progression of changes in human tumors that downregulate
Dsg1. This work promises to illuminate a new pathway by which extrinsic factors drive melanomagenesis, and
to open up avenues for development of biomarkers predictive of invasive disease and acquisition of drug
resistance, as well as cancer interception strategies for patients at high risk of developing malignant melanoma.

Public health relevance
This project aims to understand how communication pathways between epidermal keratinocytes and melanocytes that promote the UV tanning response are hijacked in the developing melanoma niche to drive oncogenesis. A central player in keratinocyte:melanocyte communication is the keratinocyte adhesion molecule desmoglein 1, which is downregulated in response to UV or signals from transforming melanocytes and melanoma cells. We will test the idea that desmoglein 1's loss stimulates keratinocytes to produce extrinsic factors that inturn cause melanocytic cells toadopt new fates that drive tumor progression.